Point of Care Technology Research Center in Primary Care - ITAP

Project Summary/Abstract
The goal of the NIH Independent Test Assessment Program (ITAP) is to create an accelerated
pathway to provide FDA evaluation of tests to assist with large-scale manufacturing.
Working closely with the NIH and FDA, CIMIT will provide dedicated ITAP resources and
manage the processes for independent laboratory validation, clinical studies, and streamlined
data collection in support of FDA emergency use authorization (EUA) applications.
CIMIT will create a process workflow and establish a streamlined process to manage the
documentation and tracking of ITAP projects. Applicants to ITAP will be evaluated for
participation based on several criteria surrounding EUA for point-of-care (CLIA-Waived), high
volume test kit manufacturing capacity, and a demonstrated capability for reproducibly
manufacturing and distributing high quality products. Applicants accepted into the program will
move through the developed ITAP workflow, including a “DASH,” and the potential for Phase 2
Testing, OTC Clinical Study or Fast Track Clinical Study.
CIMIT will leverage existing relationships between RADx and regulatory authorities to make
regulatory input available for project teams and ensure that teams utilize well-established quality
systems methods in the course of their work, in order to accelerate the availability of more high-
quality and reliable OTC tests to the public as quickly as possible.

Public health relevance
Project Narrative The goal of the NIH’s new Independent Test Assessment Program (ITAP) is to establish an accelerated pathway to support FDA evaluation of tests in order to accelerate regulatory review and availability of high-quality, accurate, and reliable over-the-counter COVID-19 tests to the public. In support of this program, CIMIT will utilize its unique experience to assist with facilitation and management capabilities for ITAP, and to develop and implement processes designed by CIMIT and proven in RADx Tech, to coordinate and oversee the ITAP program.